The role of sulfatide in the development of tauopathy in the context of ADRD

Alzheimer’s disease (AD) and its related dementias (ADRD) are the most common type of dementia in the aging
population without effective therapy to delay its onset and/or progression. Sulfatide (ST), a key myelin lipid
component, is specifically synthesized in oligodendrocytes (OLGs) in the CNS by cerebroside sulfotransferase
(CST). Our previous/preliminary studies have revealed a causal association between ST loss and increased Tau
phosphorylation (pTau). We showed that: 1. ST levels are markedly reduced at very early stages of AD and
under multiple AD risk conditions; 2. brain ST is transported by apoE particles in an isoform-dependent manner
(the lowest in the brains of apoE4 carriers); 3. the degree of pTau is inversely correlated with ST mass in human
apoE knockin (KI) mice; 4. Aβ accelerates ST loss, whereas the loss of hydroxy-containing ST (OH-ST) is more
rapid than non-OH-ST (NOH-ST) in all examined AD models; 5. ST loss in CST constitutive (CST-/-) and
conditional (CSTfl/fl/Plp1-CreERT, referred to as CST cKO) knockout mice leads to increased pTau at multiple
sites and abnormal accumulation within OLG cell bodies; 6. Mapt (highly expressed not only in neurons, but also
in OLGs) and multiple genes encoding tau kinases are markedly upregulated in OLGs of CST cKO mice as
uncovered by snRNAseq; 7. Fa2h (coding for fatty acid 2-hydroxylase) is drastically upregulated in CST KO mice
and AD brains, while myelinating glial FA2H cKO mice display a marked loss of total ST and depleted OH-ST;
and 8. expression of multiple myelin and lipid metabolism genes is significantly altered in OLGs of CST cKO
mice. These lines of evidence led us to hypothesize that ST loss leads to increased pTau and tauopathy in
OLGs, and accelerates tau seeding, spreading, and aggregation in ADRD. Further, it has been well established
that lipid rafts in OLGs play a crucial role in cellular cytoskeleton stability and integrity to regulate myelin formation
and maintenance, and sphingolipids are essential components of lipid rafts. Previous studies reported that the
upregulation of Mapt and altered expression of the genes involved in myelin lipid synthesis and metabolism are
manifest in OLGs of AD subjects as revealed by snRNAseq. These studies, along with our new findings led us
to hypothesize that disruption of OLG lipid rafts induced by ST loss is a key driver of increased pTau and then
tauopathy in OLGs in ADRD. Our Specific Aims to test the hypotheses include (1) To extensively investigate if
ST deficiency leads to increased human tau phosphorylation, accumulation, and aggregation in OLGs; (2) To
systematically determine the role of OLG tau and ST content in tau seeding, spreading, and aggregation; (3) To
identify whether ST deficiency-induced disruption of OLG lipid rafts is a key driver of increased pTau and
tauopathy in OLGs; and (4) To determine if restoring brain ST content ameliorates tauopathy in the context of
ADRD. This proposal is the first to address the knowledge gap of when, where, and how enhanced pTau occurs
following ST loss. The rigor of this proposal is built upon our new findings, and various novel animal models. If
our hypothesis is borne out, this work will provide a novel path to develop drug strategies for treatment of AD.

Public health relevance
Project Narrative: The proposed research is relevant to public health because Alzheimer's disease (AD) is the most common cause of dementia worldwide. The current application aims to understand a novel mechanism underlying lipid deficiency-induced tau toxicity and pathology in AD and related dementia. Positive results may lead to new understanding of AD pathogenesis and development of novel drugs for effective treatment of AD.